REPLACEMENT THERAPY IN ALPHA I ANTI-TRYPSIN DEFICIENCY

This study provides for the local administration of Alpha I Anti-trypsin prepared from pooled human plasma to patients with pulmonary emphysema due to a congenital absence of this enzyme.